Cardiovascular Research Training Program

ABSTRACT
This is the fifth competitive renewal of the University of Washington Cardiovascular
Research Training Program. This application requests support for a Program that
provides structured multidisciplinary research training to 5 MD, PhD, or MD/PhD trainees
per year. The Program builds on a strong tradition of cardiovascular research and
clinical training at the University of Washington School of Medicine. Training
opportunities are provided in five broad areas: 1. Signaling and Vascular Injury. 2.
Molecular and Cellular Therapies. 3. Bioengineering/Biomechanics/Imaging. 4. Genetics
and Genomics of Cardiovascular Risk. 5. Cardiovascular Population Science. The
Program supports research training with faculty who hold primary appointments in 11
distinct academic departments in the School of Medicine and School of Public Health.
The faculty is highly collaborative as evidenced by joint publications, co-mentoring of
trainees, and participation in Program Projects and Center grants. The faculty also has
a long track record of successful mentoring and support of trainees. Several early
trainees of this Program now hold senior academic positions around the country.
Training supported by this Program includes mentored research experience under the
primary direction of our Program faculty and group activities such as didactic courses
and seminars. Each of our trainees has a tailored training plan that is designed to
promote early success, to broaden scientific knowledge and expertise, and to enhance
essential career skills. The Program is the major source of support for clinical fellows in
Cardiology who wish to acquire skills necessary to become independent principal
investigators in cardiovascular research. The Program is also a critical source of support
for trainees with PhD degrees who wish to pursue training in either basic or population-
oriented cardiovascular science.

Public health relevance
PROJECT NARRATIVE The goal of this T32 program is to train independent investigators for careers in cardiovascular research focusing on both basic science and population sciences. This program supports full time research training for individuals with doctoral degrees (MD, PhD, or both). Research training is provided in several areas including: identifying the causes of cardiovascular diseases, improving our ability to diagnose and treat and prevent cardiovascular diseases.